CSHL 2024 Conference on Glia in Health & Disease

2024 Cold Spring Harbor Laboratory Conference
GLIA IN HEALTH & DISEASE
August 20 – 24, 2024
Abstract
The proposed meeting on Glia in Health & Disease will be held August 20 – 24, 2024 at Cold Spring Harbor
Laboratory. The goal of this conference is to provide an active forum for exchange of results in the rapidly
advancing fields of glial biology and neuron-glia interactions. Glial cells comprise a diverse group of non-
neuronal cells that are essential for nervous system development, circuit function, and disease. Glia perform
many important roles, such as regulating the development of neural circuits, modulating neurotransmitter
signaling between neurons, providing metabolic support to many nervous system cells, supporting the fast and
efficient propagation of action potentials, modulating vascular development and blood flow, and regulating the
propagation of pathology and inflammatory cascades in disease. With the advancement of genetic tools to
specifically target glia, we are now gaining a deeper mechanistic understanding of how glial cells function in
health and disease. This includes mechanisms highlighting glia actively modulate neural circuit function,
plasticity, and behavior under healthy, steady-state conditions. We are also now appreciating how these
functions go awry in pathological states, leading to circuit dysfunction, chronic inflammation, and destruction of
neurons and their synaptic connections. There are also clear indications that glia may not only react to
diseased neurons to propagate disease, but they are a part of the underlying etiology. For example, many
gene mutations linked to neurodegenerative diseases, such as Alzheimer’s disease and multiple sclerosis, are
in genes enriched in glia. Further genetic manipulation studies are beginning to reveal how these mutations
alter glial cell function and contribute actively to the earliest initiation and propagation of these diseases.
Adding to the complexity in disease, glia can also be beneficial and promote regeneration and tissue repair by
performing functions such as providing metabolic support, engulfing debris, and forming protective glial scars.
This meeting will highlight the latest developments in glial cell biology obtained through studies of invertebrate
and vertebrate model systems, as well as human tissue and cells, using the most up-to-date genetics,
molecular biology, biochemistry, physiology, and imaging technologies. Using the goals and format of the
previous nine extremely successful meetings as a guide, we will: 1) assemble a diverse meeting of scientists
engaged in studies of glial biology and neuron-glia interactions; 2) showcase the newest and most exciting
developments through talks selected based on scientific merit from openly submitted abstracts; 3) empower
junior scientists to present their work and engage with established investigators; and 4) foster collaborations for
accelerated discovery.

Public health relevance
2024 Cold Spring Harbor Laboratory Conference GLIA IN HEALTH & DISEASE PROJECT NARRATIVE The intricate functioning of the nervous system relies not only on the activity of neurons but also on the crucial contributions of glial cells. The “Glia in Health and Disease” conference, hosted biennially since 2006, remains the preeminent glial meeting. This meeting unites a diverse assembly of researchers investigating basic, fundamental biological mechanisms by which glia contribute to brain circuit development and function to translational neuroscientists who identify new glia-based targets for therapeutic intervention. Above all, the conference strategically engages leaders, seasoned investigators, and early-career scientists to interact and collectively share their latest discoveries on the intricate roles of glial cells in the nervous system.